CRCNS: US-Israeli Research Proposal: Deciphering reorganization of multi-regional activity following category learning

PROJECT SUMMARY (See instructions):
Learning is a fundamental component of neural systems. It is essential for gaining new knowledge or skills,
and impaired learning faculties can have major deleterious effects. Although various forms of associative
and perceptual learning have been studied our current understanding of how neural circuits learn remains
incomplete. Humans and animals leverage category learning––grouping stimuli together based on shared
and often higher order features––to deal with the world’s dazzling complexity. Yet, the neural mechanisms
underlying category learning are not known. In this proposal, we focus on auditory category learning
leveraging the rich nature and dynamic structure of natural and synthetic soundscapes. Auditory category
learning is ubiquitous across the animal kingdom, with vivid examples from invertebrates to humans, and is
intimately related to the transformation of sound to percepts. However, mechanistic studies of category
learning in audition are not yet mature. In mice, where powerful experimental toolkits exist and new tools
are continuously developed, studies of auditory category learning are scarce. Here we will study the multi-regional basis of reshaping of population activity following learning. We will analyze a unique dataset of
simultaneous population recordings across brain areas in mice learning an auditory categorization task. We
will apply novel computational methods to study how cortical auditory circuits process sounds and how this
processing changes following learning. We will explore multiple types of trained categorization as well as
responses to categories of natural sounds. We will characterize changes both at the level of single neurons
and at the level of neuronal populations. Through simultaneous recordings across brain areas we will
delineate changes both at the level of individual brain areas and at the level of interactions between brain
areas. Finally, we will use perturbations to improve our causal understanding of the circuitry. These
experiments and analyses will allow us to explore specific hypotheses regarding the plasticity and circuit
computations of cortical circuits in the mammalian brain, and how these support category learning.

Public health relevance
RELEVANCE (See instructions): Deterioration and loss of hearing has a major negative impact on quality of life for millions of Americans. Learning induced circuit changes interact with hearing loss at multiple levels from learning induced changes ameliorating perception despite hearing loss through the effect of hearing loss in children during times of substantial learning plasticity, to learning following use of devices such as cochlear implants. Understanding how learning affects auditory representations is crucial in treating hearing loss and ameliorating quality of life.